The Role of ERRa in liver lipid dysfunction and pathology

Estrogen-related receptor (ERR) plays critical roles in the transcriptional regulation of genes involved in mitochondrial bioenergetics, TCA cycle, mitochondrial oxidative phosphorylation, and fatty acid -oxidation. This project intends to discover the roles of ERR as novel transcriptional factor for lipid metabolism and its involvement in pathology development in the liver. To address the function of ERR in dyslipidemia, we developed a novel small molecule inhibitor (ERR-PA) that can block the binding of ERRs to the promoters of their target genes. Using this compound in diet and genetic models of liver steatosis (NAFLD/ALD) and steatohepatitis (NASH/ASH), our preliminary studies showed that inhibiting ERR robustly blocks the development of steatosis and reverses the lipid accumulation in models where liver steatosis is induced by diet and ethanol feeding as well as genetic alterations. ERR-PA also significantly reduced the fibrosis and inflammation occurring in established steatohepatitis. Using these in vivo as well as in vitro systems, we will explore the molecular mechanisms by which ERR inhibition suppresses the progression of liver disease. The hypothesis to be tested is that ERRs positively regulate transcription of genes encoding enzymes for anabolic lipid metabolism and inhibiting this action blocks steatosis and associated inflammation and fibrosis in NASH/ASH. We will address this hypothesis with the following three aims. Aim1 will investigate the regulation of liver lipid metabolism via the transcriptional activity of ERRs. This aim will explore the transcriptional complex by which ERR regulates de novo lipogenesis, glycerolipid biosynthesis and fatty acid -oxidation. Aim2 will determine the effect of ERR inhibition on oxidative lipid damage during ASH/NASH development. This aim will investigate lipid, oxidized lipid and other derivatives, ROS production and their contribution to liver damage. The proposed project explores ERR as a potential target for inhibiting and reversing fatty liver diseases. The mechanistic and translational approaches will uncover novel biology for lipid metabolism as well as test the therapeutic effect of a small molecule polyamide.

Public health relevance
Fatty liver disease occurs in about 25% in the general population of the United States and as high as 70% in the obese population and those with Diabetes; and in individual who consume alcohol. With the increase in obesity rate and continued excessive drinking behavior in the US population, fatty liver is in line to become the leading cause of liver transplantation in the next 10 years. This project will study the molecular changes occurring with fatty liver using mouse models. We also designed an inhibitor to block the signal that we have discovered. We expect this inhibitor to exhibit therapeutic effect at treating fatty liver disease.